Integrated Biological Systems Training in Oncology

PROJECT SUMMARY
The objective of this second renewal of the Integrated Biological Systems Training in Oncology (IBSTO)
program is to continue to prepare predoctoral students and postdoctoral fellows for careers in cancer
research with comprehensive training in basic and translational research. IBSTO training focuses on basic
cellular processes and mechanisms that are shared between cell biology and developmental biology that
are critical to understanding how cells become tumorigenic and on how to translate this basic research
knowledge to the diagnosis, treatment and prevention of cancer. The IBSTO program takes place in an
active and growing environment with state-of–the-art facilities, a vibrant NCI-designated comprehensive
cancer center, top-ranked basic science departments, an Interdisciplinary Graduate Program in Biomedical
Sciences, and an active Office of Postdoctoral Affairs. In our first nine years, we have recruited 42
outstanding predoctoral and postdoctoral trainees that have been very productive. Trainees have been
placed with experienced, well-funded, productive preceptors in an interactive research environment with
extensive resources. The three broad areas of experience of our preceptors are in cell biology,
developmental biology/genetics and medicine. The goals of our training program are to provide proactive
mentoring and oversight, provide cross-discipline education and research, provide training in cutting edge
methodology, develop useful academic skills, foster interactions with faculty and other trainees, provide
exposure to current cancer research discoveries, and provide exposure to clinical cancer treatment and
translational research. In this renewal, we have strengthened our training activities by adding a new IBSTO
Day Retreat, a new cross-disciplinary collaboration workshop, and bolstering our clinical/translational cohort
of preceptors. We have also added a new External Advisory Board to provide ongoing feedback and
evaluation of the program. And we have a new Program Director who has a strong record of basic cancer
research and administrative experience. We believe that integrating basic science research training in cell
biology, developmental biology and genetics with translational and clinical experience allows a better
understanding of the multiple lesions in cellular processes that define cancer, which is critical to diagnosing,
treating and eventually preventing of this disease.

Public health relevance
NARRATIVE The Integrated Biological Systems Training in Oncology (IBSTO) program prepares predoctoral students and postdoctoral fellows for careers in cancer research with comprehensive training in basic and translational research. The IBSTO program takes place in an active biomedical research environment with state-of–the-art facilities, experienced preceptors in an interactive education and research environment with extensive resources and institutional commitment. The IBSTO program provides our productive trainees unique mentoring, useful academic skills, interactions with faculty and other trainees, exposure to current cancer research discoveries and exposure to clinical cancer treatment and translational research.